Genotoxicity and immunogenicity of the uropathogenic specific protein (USP) in the gut

PI: Baerga-Ortiz, Abel
Title: Genotoxicity and immunogenicity of the uropathogenic specific protein (usp) in the gut
Project Summary
The uropathogenic specific protein (USP) is a multi-domain protein with nuclease activity
harbored by some uropathogenic strains of Escherichia coli. The protein has been shown to
cause damage to cultured endothelial cells. Although USP is primarily associated with urinary
tract, the USP gene has been found in a large percentage of fecal samples screened across
populations in Japan, USA and Puerto Rico. The presence of USP in fecal samples raises the
question of 1) whether USP is toxic to the gastrointestinal tract and 2) whether this toxicity is a
risk factor for intestinal disorders. This proposal is an effort to understand the gut-specific
activity/toxicity of purified USP. Our group has already expressed and purified a USP
protein with high nuclease activity. This R16 proposal details work that will be performed
entirely by students, in which purified USP will be used to: 1) Investigate toxicity of USP
against cultured patient-derived intestinal organoids, 2) Delineate possible mechanisms of
USP entry into cultured patient-derived intestinal organoids, and 3) Explore whether the
presence of USP in fecal samples is correlated with an anti-USP antibody response. All of the
proposed experiments will help to ascertain a possible gut-specific activity of USP, which may
impact disease risk.

Public health relevance
PI: Baerga-Ortiz, Abel Title: Genotoxicity and immunogenicity of the uropathogenic specific protein (usp) in the gut Project Narrative Over the last decade, there has been an explosion of interest in the role of the gut microbiota in the maintenance of human health. While the gut microbiota is generally considered to be beneficial, certain microbial strains have been found, some widely distributed in the population, that harbor toxins and other negative effectors. This proposal aims to dissect the possible damaging effects to intestinal cells of the bacterial uropathogenic specific protein (USP), a toxin originally identified in urinary tract infections, but also found in the GI tract.